Determining cell-type specificity for a nonclassical MHC class I during an activity-dependent cortical critical period.

7. Project Summary/ Abstract
The long-term goal of this research is to understand how neural activity sculpts brain circuits during
developmental critical periods. In cerebral cortex, synapses are pruned or stabilized in relation to levels and
patterns of activity and normally this process occurs extensively during critical periods and is highly specific. In
disease and inflammation, activation of glia can drive excessive pruning and perturb synaptic plasticity.
Systematic approaches to treating pruning disorders in disease require understanding cell and molecular
mechanisms normally engaged in synapse plasticity and remodeling. In healthy brain, we have discovered that
Qa-1, a nonclassical Major Histocompatibility Class I (MHCI) molecule (gene name H2-T23; human HLA-E), is
highly expressed in L6 of cerebral cortex and may contribute to activity-dependent plasticity in visual cortex. Qa-
1 has been studied in peripheral immune cells, but until now nothing was known about expression or function in
healthy brain. However, Qa-1/HLA-E has been detected in neurons and glia in inflammation and Alzheimer's
disease. Experiments proposed here test the hypothesis that Qa-1 expression in neurons restricts sensory-
driven plasticity in visual cortex during the critical period. Two specific aims are proposed: 1) Identify cell type
expression, activity-regulation and subcellular localization of Qa-1 mRNA in cortex. Cell types expressing Qa-1
mRNA will be identified by RNAScope in situ hybridization in combination with neuronal or glial-specific markers.
Visual experience will be manipulated to test if Qa-1 expression is regulated, as occurs for many genes known
to mediate activity-dependent plasticity. RiboTag cell type specific gene profiling will be used to detect Qa-1
mRNA isolated specifically from neurons, microglia and synaptosomes. The presence and enrichment of Qa-1
mRNA in L6 cortical neurons and synaptosomes will provide clues about how Qa-1 regulates plasticity during
the critical period. 2) Generate a conditional allele of Qa-1 and explore cell-type specificity of Qa-1 function in
activity-dependent plasticity. To dissect neuronal vs glial Qa-1 function, the Easi-CRISPR method (Quadros et
al. 2017) will be used to insert loxP sites into the H2-T23 gene. Once a stable line is generated, Qa-1fl/fl mice will
be crossed to Cre-expressing lines to generate mice lacking Qa-1 in neuronal vs glial cell populations. These
lines will then be studied for activity-dependent phenotypes including ocular dominance plasticity and an activity-
dependent microglial response. Results should reveal if Qa-1 acts in neurons, in glia or both for intact activity-
dependent plasticity in visual cortex. If Qa-1 is required specifically in L6 neurons, results would imply a key role
for this MHCI in a major circuit connecting thalamus and cortex. These studies of visual cortex should have broad
significance because Qa-1 is expressed throughout neocortex. Moreover, the Qa-1 ortholog HLA-E is expressed
in human cerebral cortex, so our studies may illuminate how this MHCI normally functions in human brain, and
also contribute to understanding the basis for disorders in which activity-dependent synaptic plasticity and
pruning go awry, as are thought to occur in Amblyopia, Autism, Schizophrenia and Alzheimer’s disease.

Public health relevance
8. Project narrative These proposed studies identify a novel and unexpected role for a nonclassical Major Histocompatibility Class I molecule expressed in neurons the healthy brain and possible role in activity-dependent development. MHCI molecules are modulated by inflammation and upregulated in Alzheimer's disease, providing an avenue for direct cross talk between neural and immune cells bearing appropriate MHCI receptors. This work should broaden mechanistic understanding of how use-dependent changes are encoded in the structure of neural circuits during developmental critical periods in the healthy brain and also contribute ultimately to efforts to cure neurodevelopmental and neurodegenerative disorders involving alterations in synapse plasticity and pruning.